Adaptive Testing of Cognitive Function based on multi-dimensional Item Response Theory

Project Abstract
With the aging of the American population, the number of older adults at risk for developing cognitive
impairment is staggering. Recent research points to age-related change in cognitive performance beginning as
early as age 30, highlighting the potential for early interventions. Cognitive function has long been assessed
using standardized cognitive tasks administered via neuropsychological evaluation. However, the traditional
way to assess cognitive ability is time consuming, requires trained personnel, requires an office visit, and
identifying decline among younger adults is particularly challenging because it can be masked by item
redundancy effects. Here we propose developing a new computerized adaptive test (CAT) to assess cognitive
function, either in clinic or remotely, that is based on recent advances in multidimensional item response theory
(MIRT). We are calling it the CAT-COG. The CAT-COG will assess global cognitive ability as a primary domain
as well as 5 cognitive subdomains: episodic memory, language/semantic memory, processing speed,
attentional control/working memory, flexible cognition/reasoning. Our approach will revolutionize computerbased
cognitive testing (ultimately in a platform independent way), providing precise estimation of an
individual's ability on these domains with minimal respondent burden, using a sufficienUy large bank of items
so that the same individual's cognitive ability can be assessed repeatedly without reusing items or stimuli. This
project (resubmission) brings together an accomplished interdisciplinary team of researchers and also builds
on the unique resources of the Rush Alzheimer's Disease Center (RADC). A portion of the original Aim 1 of the
grant that involved development of a new 500 item bank of cognitive tasks, data collection, bifactor model
calibration and simulated adaptive testing has now been independently funded by an NIA R56 award (2 years
of what we proposed to complete in 3 years). These are the key remaining project steps: (1) We will expand
our Ml RT-based model calibration to include a wide variety alternative IRT/MIRT models (bifactor, unrestricted
MIRT, domain-specific IRT, TesUet and trifactor models) and select the best fitting model(s) for the final CATCOG.
Note that different models may be used for the global and domain specific tests. (2) We will validate the
CAT-COG among returning RADC participants who will also receive traditional neuropsychological testing. (3)
We will study short-term variability of the CAT-COG to determine learning effects, develop a testing protocol
that is immune to such effects, and assess test-retest reliability. (4) We will harmonize the CAT-COG with the
RADC standard test battery so that existing data can be linked to newly collected CAT-COG assessments. (5)
Assess differential item functioning to detect possible bias as a function of age, race, sex, and education.

Public health relevance
Project Narrative This project aims to build the first computerized adaptive test based on multidimensional item response theory to more precisely, rapidly, and repeatedly assesses cognitive abilities, compared to existing gold-standard in- person neuropsychological testing. This assessment will be suitable across the adult lifespan (from cognitively normal younger adults to older adults with MCI), thereby advancing early detection of cognitive decline associated with Alzheimer’s disease. It also would be available online, thereby increasing accessibility in underserved populations and providing a new tool for basic and applied research.